Animal Models for Assessing the Relative Abuse Liability of Tobacco Products

PROJECT SUMMARY (See instructions): The goal of this component of the P01 application is to develop methods to evaluate the relative abuse liability of tobacco products in animals. The tobacco industry is introducing several

Public health relevance
RELEVANCE (See instructions): The FDA is now required to evaluate and regulate tobacco products toward the goal of protecting public health. This study will develop animal models to assess the relative abuse liability of several tobacco products using aqueous extracts of those products that provide a range of constituents similar to product exposure in humans. In concert with humans studies in this POI, these models may be useful for anficipafing the likelihood and extent of population-level abuse of new tobacco products in humans and its associated impact on public health. They may also help understand how chemicals other than nicotine contribute to tobacco addiction and suggest relevant performance standards for tobacco products to limit or reduce their addictiveness.